Vanderbilt Institute for Clinical and Translational Research (VICTR) -Identifying correlates of functional immunity in SARS-CoV-2 convalescent plasma

The Vanderbilt Institute for Clinical and Translational Research (VICTR) is a highly functional and integrated clinical and translational (C&T) research infrastructure that has raised the quality and scientific rigor of the research conducted at Vanderbilt and longstanding partner Meharry, the nation's oldest historically black academic health science institution. VICTR will contribute to the mission of the CTSA program while leveraging unique resources and expertise within VICTR's Hub with these aims: 1) Leverage VICTR's strong collaborative energy to enhance team science methodologies that propel transdisciplinary research approaches, and integrate proven community engagement principles to stakeholders for all stages of research; 2) Develop, implement and disseminate informatics and data organization methods to promulgate research efficiency, quality, and preparedness and integrate data collection in the conduct of pragmatic trials; 3) Ensure the translational science workforce is diverse and has the skills, knowledge, and resources necessary to advance translation of discoveries; 4) Measurably improve the efficiency, quality, and representativeness of C&T studies by enhancing and systematically integrating services and programs that support highest quality research initiation and conduct; 5) Measurably improve the efficiency and quality of multi-site clinical trials, in collaboration with the TICs and RICs, by leveraging centralized regulatory and legal agreements, providing rapid feasibility and recruitment methods and practices, and creating and disseminating novel clinical trial designs and methodologies; and 6) Utilize unique strengths leveraging novel resources BioVU and PheWAS to guide drug development and repurposing.

Public health relevance
PROJECT NARRATIVE The COVID-19 pandemic is a rapidly growing unmet medical need that has resulted in the infection of 6 million and the death of over 180,000 individuals in the United States; yet only two therapies have demonstrated clinical efficacy against this virus to date and only in subsets of patients, thus making it imperative to identify additional treatment options. Anti-SARS-CoV-2 convalescent plasma treatment offers an accessible and practical form of therapy for COVID-19 and randomized clinical trials are underway to determine the safety and efficacy; however, due to the wide variety of assays and methodologies being used across the country to determine the presence and/or quantity of SARS-CoV-2 antibodies in plasma it is currently impossible to provide uniform guidance on selection of optimal units of plasma for transfusion. The purpose of this project is compare the results of several measures of antibody binding and viral neutralization and correlate these results with participant outcomes to elicit not only key relationships between qualitative/quantitative antibody assays and viral neutralization capabilities, but also provide correlates of functional immunity.